Climate & Health Actionable Research and Translation Center

CHART: RESEARCH CAPACITY BUILDING CORE – SUMMARY
The Climate & Health Actionable Research and Translation (CHART) Center aims to generate knowledge
about the health risks associated with climate change in urban areas, particularly those related to heat
exposure, and translate this knowledge into action through equitable partnerships that enhance health. Low-
income and minority communities in the US and low- and middle-income populations globally face severe
challenges arising from climate change, especially from heat, and CHART aims to address these challenges.
The Research Capacity Building Core (RCBC) aims to build the capacity of climate change and health (CCH)
researchers in Emory, their US and global partners, and physicians serving the communities at-risk in Atlanta
through tailored learning, direct research experience, and networking, to translate CCH research discoveries
into real-world policies and practice. To achieve this goal, the RCBC proposes three specific aims. First, the
RCBC will build CHART researchers' capacity to implement and adapt transdisciplinary CCH research within
their specific system and community context through tailored skills-building and learning opportunities. Second,
RCBC will establish a pilot project program for investigators at any career stage with promising climate and
health research proposals to generate data needed to demonstrate technical feasibility. Finally, the RCBC will
leverage a community of practice to encourage new transdisciplinary research partnerships, new CCH
research projects, and translation of evidence to action. The RCBC is crucial to CHART's vision to be a hub
that advances and translates research in the climate risks to protect the health of under-resourced urban
populations. The RCBC will implement new and inclusive approaches to enhance the CCH research capacity
of transdisciplinary teams from epidemiology, exposure science, medicine, biostatistics, social and behavioral
science, and public policy, as well as community partners. This will lead to more expansive approaches to
identify and address gaps in our understanding of the differential susceptibilities to heat exposure in under-
resourced urban communities, with a focus on interventions that are most impactful and feasible.